CHILD CARE AND DEVELOPMENT FUND (CCDF) POLICIES DATABASE PROJECT

The overall purpose of this task order is to continue the development of the Child Care and Development Fund (CCDF) Policies Database, a comprehensive, up-to-date, and publicly accessible database of child care subsidy policies for the 50 states, the District of Columbia, and U.S. territories. The specific goals include: (a) maintaining and updating the database; (b) producing reports and data files that capture key cross-state variations in CCDF policies; (c) implementing and supporting an interface that allows users to directly query the database; and (d) promoting the use of the CCDF Policies Database in child care policy research through dissemination activities and improvements to the user experience.